Investigating the effect of alcohol exposure on human cortical development using a 3D in vitro model

Project summary
This project is prepared in response to PA-20-272 (Administrative Supplements to Existing NIH Grants and
Cooperative Agreements (Parent Admin Supp Clinical Trial Optional). The PI is in no cost extension period
of her F32 fellowship, partially supported by funds carried forward from previous years. The PI successfully
generated human iPSC-derived cortical spheroids in defined, differentiation-promoting culture medium and
investigated the effect of ethanol on early brain development. We have assessed the effects of ethanol on
cortical development by monitoring cell death, morphological change, cellular proliferation, and the
progenitor cell population with an emphasis on outer radial glia-like cells in the spheroids at cellular level.
This proposed administrative supplement will allow the PI completing analysis of acquired RNA sequencing
data in preparation of future manuscript. This administrative supplement will also provide the necessary
resources allowing an orderly completion of the parent project.

Public health relevance
Project Narrative Human induced pluripotent cells (hiPSCs) are capable of becoming variable types of cells providing they are supplied with appropriate combinations of environmental cues in the culture. This project proposes using hiPSCs to generate spheroids that contains the cellular populations similar to very early developing brain. These spheroids then would be exposed to ethanol, mimicking the cause of fetal alcohol spectrum disorder, thus to provide insights of how the developing brain responds to the stress from ethanol.